(8) Genetics of Immune Related Adverse Events and Response to Immunotherapy

PROJECT SUMMARY/ ABSTRACT
Therapy with immune checkpoint inhibitors has substantially increased survival of patients with metastatic
melanoma, lung cancer, head and neck cancer, bladder cancer, renal cell carcinoma and others. However, a
majority of patients have very limited or no response to these drugs. In addition, a large fraction of patients
have significant side effects including immune related adverse events (irAEs). Somatic mutation load,
neoantigen burden, and some particular somatic mutations can help predict response to therapy; however,
currently available predictors have only modest power to predict response and there are no good predictors of
irAEs. Thus, novel biomarkers may be helpful in predicting irAEs and understanding their etiology. We
hypothesize that irAEs are manifestations of autoimmunity in individuals who are genetically susceptible to
autoimmune disorders and that the genetic variants underlying common autoimmune disorders will also be
useful predictors for irAEs. Separately, we and others have demonstrated that autoimmunity may be
associated with response to immunotherapies. Thus, we hypothesize that there will be shared genetic factors
underlying response to immunotherapy and irAEs. We will test these hypotheses in a cohort of over 3000
patients with non-small lung cancer receiving programmed cell death 1 (PD-1) inhibitors.
We will perform both targeted sequencing of the human leukocyte antigen (HLA) region and genotyping with a
genome wide single nucleotide polymorphism (SNP) array. We will use these data to test the association
between HLA and irAEs. We will also determine whether combinations of SNPs and HLA haplotypes known to
be associated with autoimmune diseases can be used to predict irAEs. Finally, we will search for novel SNPs
associated with irAEs. We will also investigate whether genetic factors that may affect survival of patients on
immunotherapy. We will use the HLA sequence data and GWAS data to search for variants associated with
overall survival. We will also leverage data from The Cancer Genome Atlas (TCGA) Project to identify genetic
variants that affect immune signatures in the tumor known to be associated with response to immunotherapies
such as lymphocyte infiltration and PDL1 expression. We will investigate whether the genetic variants identified
in TCGA affect response to immunotherapies. Finally, we will investigate whether there is shared genetic
predisposition to irAEs and to beneficial response from PD-1 inhibitors. At the conclusion of this work, we will
develop an understanding of the genetic profile that underlies patients' risk of irAEs.

Public health relevance
PROJECT NARRATIVE Immune therapies have extended the lives of many cancer patients; however, patients receiving these therapies frequently suffer autoimmune side effects, in which the immune system attacks various tissues. We propose to evaluate whether inherited genetic variants may predispose some patients who receive these therapies to the autoimmune side effects and whether there are genetic variants that affect the response to immune therapies.